Characterizing the Unique Biophysical Properties of the CBC2 OFF Cone Bipolar Cell

PROJECT SUMMARY
Bipolar cells (BCs) are the first interneurons in the retina and are responsible for sampling photoreceptor output
and distributing it to ON and OFF streams. Each BC subtype collects and transforms different salient components
of the visual scene (luminance, frequency, contrast, etc.), yet the specific mechanisms different subtypes use to
process this information into functional channels remain elusive. This proposal focuses on the CBC2 (Type 2
OFF cone bipolar cell). In addition to its conventional role processing photoreceptor output for downstream retinal
ganglion cells, the CBC2 is the primary recipient of inhibitory crossover inhibition from AII amacrine cells and
provides the majority of glutamatergic feedback onto AIIs, positioning it as an important mediator of bidirectional
signaling between ON and OFF steams across the retina. This project will characterize distinctive and novel
physiological features of CBC2s to determine their unique contribution to retinal function. My preliminary
experiments have identified three particularly interesting features of CBC2s that have not been seen in ON-BCs.
I hypothesize that CBC2s, and perhaps OFF-BCs in general, possess unique mechanisms that are likely
fundamental to their role in the retina. This proposal will examine each feature through three primary aims.
Aim 1 will use electrophysiology, pharmacology, and super-resolution immunofluorescence microscopy to
identify and characterize a postsynaptic glutamate receptor in CBC2 dendrites that may augment conventional
excitatory input from photoreceptors. Aim 2 will combine patch-clamp electrophysiology with time-resolved
membrane capacitance measurements to examine the consequences of microdomain control of vesicle
exocytosis on short-term plasticity and the voltage-dependence of exocytosis. Finally, Aim 3 will investigate
reciprocal glycinergic feedback between CBC2s and AII amacrine cells and use Ca2+ imaging and computational
modeling to create a biophysical model of glutamate release from CBC2s. Combined, these experiments
represent the first comprehensive examination of the biophysical properties of the mammalian CBC2, a vital step
in determining the role it plays in retinal function. While the von Gersdorff lab has a proven and published record
in the realm of retinal biophysics, my proposal will require learning diverse and novel techniques, such as super-
resolution microscopy and computational modeling, for which I have sought specialized training from outside my
lab. I have carefully assembled a mentorship team to provide me with the technical expertise and dedicated
guidance required to achieve my planned scientific aims and further my professional goal of a career in academic
research.

Public health relevance
PROJECT NARRATIVE Bipolar cells are the first interneurons of the retina primarily responsible for sampling photoreceptor input and distributing it into ON and OFF visual streams, yet new research suggests that each bipolar cell subtype collects and transforms different salient components of the visual scene (luminance, frequency, contrast, etc.) in different ways. This project will use super-resolution microscopy, Ca2+ imaging, electrophysiological techniques, and biophysical modeling to examine distinctive synaptic mechanisms in CBC2 Type 2 OFF cone bipolar cells and determine their unique contribution to overall retinal function. This knowledge is vital for producing a more comprehensive understanding of retinal physiology and developing new solutions to address human visual dysfunctions, and is a central goal in vision research.